Vaccine and Treatment Evaluation Units: Overall Administration, Clinical Operations Support, Protocol Development, Implementation and Assays

This program is comprised of a consortium of individual contracts within academic centers and organizations that provide a ready resource for the design and conduct of clinical trials to evaluate promising products to combat infectious diseases. In general, products will be evaluated in normal healthy populations.